Clinical Research and Epidemiology in Diabetes and Endocrinology

Summary
Diabetes mellitus is an epidemic and a major cause of blindness, kidney disease, amputation and cardiovascular
disease around the world. Other endocrinologic and metabolic diseases also have major implications for public
health. We urgently need to train patient- and population-oriented researchers to provide an evidence base for
the optimal prevention and treatment of these conditions. Researchers need methodologic training and skills in
chronic disease epidemiology, clinical trials, health services delivery and implementation science to improve
health equity and health outcomes. For the past 20 years, our T32-supported training program has played an
essential role in training the next generation of patient- and population-oriented researchers in diabetes,
endocrinology, and metabolism. Since its inception, we have successfully trained 25 pre-doctoral and 25 post-
doctoral scholars, who have authored 212 peer-reviewed papers during training. Many of these former trainees
now hold research positions across the country with NIH-funded research programs (see Progress Report). We
have trained 12 individuals underrepresented in science and medicine and 23 women. At Johns Hopkins there
is increasing breadth and depth of endocrinology and diabetes research across schools and departments,
particularly with newly funded interdisciplinary programs focused on cardiometabolic health equity and diabetes
management and prevention. In this next cycle we propose to unite this research training into single program to
promote multidisciplinary collaboration and thereby better address the real-world challenges facing our
communities. We propose to double the number of mentors from across the institution, providing diverse
expertise in multiple research areas in diabetes and endocrinology, with a particular emphasis on diabetes,
diabetes prevention and metabolic disease throughout the life course, health disparities and equity, and special
populations disproportionately affected by diabetes and endocrine diseases (e.g., persons with mental health
disorders, cystic fibrosis, and HIV). The vast research resources available at Johns Hopkins will support the
training of additional fellows. We plan to recruit diverse trainees in adult and pediatric endocrinology, General
Internal Medicine (post-docs) and public health or epidemiology (pre-docs) from a national pool of applicants;
provide a rigorous training experience in patient-oriented and epidemiologic research in diabetes, endocrinology
and metabolism; utilize existing data from well-characterized cohorts and trials to enable trainee projects to be
rapidly executed; engage trainees in high caliber collaborative research to address important questions and test
meaningful hypotheses under the supervision of nationally renowned, multidisciplinary faculty; integrate multi-
layered mentorship for each trainee to develop scholarship and an investigative career; evaluate the outcomes
of the program and make modifications to maximize its success. We will demonstrate our impact through training
and developing the careers of exceptional clinical and epidemiologic academic researchers committed to the
prevention and management of diabetes and other endocrinologic and metabolic health conditions.

Public health relevance
Project Narrative This T32 application entitled “Clinical Research and Epidemiology in Diabetes and Endocrinology Training Grant” aims to expand the impact of our rigorous research training of pre- and post-doctoral fellows. We will address a critical need for outstanding researchers and leaders who will impact the field of diabetes, diabetes prevention and metabolic disease throughout the life course and in vulnerable populations disproportionately affected by diabetes and endocrine diseases.